Dissecting the stress circuits of the paraventricular nucleus of the thalamus

This fiscal year we successfully launched our research program aimed at studying the role of the PVT in stress processing and the control of stress susceptibility. This included designing and setting up laboratory equipment, hiring and training laboratory staff, and conducting pilot studies. To begin investigating the role of PVT in stress processing, we first designed and implemented a behavioral protocol that reliably measures stress memory across many different mouse strains and genetic lines. Second, we identified putative cellular substrates of stress in PVT some of which are likely to be associated with stress-induced chances in gene expression. Finally, we drafted and published a review article that summarizes current literature on the neuronal pathways controlling the retrieval of aversive memories and proposed a model supporting the involvement of PVT in this process.